Biospecimen Core

PROJECT SUMMARY – BIOSPECIMEN CORE
The Biospecimen Core is designed to provide expert support to the translational research efforts of the
Memorial Sloan Kettering Cancer Center (MSK) Pancreas SPORE. The Core will leverage and extend the very
active tissue banking program and molecular diagnostics capabilities of the MSK Precision Pathology
Biobanking Core (PPBC), which anchors 4 other MSK SPOREs and the MSK Center for Pancreatic Cancer
Research. The SPORE Biospecimen Core will play an essential role in collection, annotation, storage,
distribution, and tracking of pancreatic cancer biospecimens (tissue and blood) from patients enrolled in
institutional biospecimen banking protocols and therapeutic research protocols. Detailed biospecimen
annotation, including documentation of preanalytic processing variables, pathology findings, and patient clinical
history information will be recorded in robust relational databases. We will conduct rigorous data quality
assurance and quality control measures, and standardized longitudinal follow-up of all consented patients with
materials in the pancreatic cancer biospecimen repository. The Core will also provide SPORE investigators
with expert histopathological evaluation of tumor samples, as well as assistance in performing and interpreting
immunohistochemical assays, selecting tissue for microdissection for downstream analysis, constructing tissue
microarrays, and facilitating patient-derived organoid creation. The specific aims of the core are to (1) maintain
and expand the collection, annotation, and storage of biospecimens for pancreatic cancer research, (2) perform
systematic pathologic evaluation of all relevant ductal pancreatic adenocarcinoma samples and to prepare
appropriate biospecimens for use by SPORE investigators, and (3) provide systematic microscopic
assessment of response to therapy. Given the significant heterogeneity of pancreatic cancers, each of these
aims requires expertise beyond what existing resources can provide, underscoring the need for this Core. All
of the research projects will rely extensively on the Biospecimen Core to achieve their translational research
objectives.

Public health relevance
NARRATIVE – BIOSPECIMEN CORE The Biospecimen Core will support the work of the Memorial Sloan Kettering Cancer Center (MSK) Pancreas SPORE by playing a critical role in the collection, annotation, and storing of all tumor samples and blood from patients with pancreatic neoplasms enrolled in research protocols at MSK. The core will provide centralized expertise in pathological diagnosis, tissue selection for molecular analysis, and interpretation of ancillary techniques to assist the translational research goals of the SPORE investigators.